Descending facilitation of pain by mu-opioid receptor-expressing neurons in the rostral ventromedial medulla

Project Summary/Abstract
Pain is a debilitating and prevalent condition which severely impacts quality of life. Unfortunately, our current
treatment options are limited by adverse effects, and the pathways modulating pain signaling are not fully
understood. The rostral ventromedial medulla (RVM) is a brainstem site which plays a critical role in pain
modulation, primarily by sending descending projections to the spinal cord. While non-specific electrical
stimulation of the RVM produces analgesia, RVM neurons can either facilitate or inhibit pain. RVM spinal
projections can be characterized as ON-cells, OFF-cells, or NEUTRAL-cells based on their response to, and
effect on, nocifensive reflexes, but many details remain unclear. Morphine acts at the mu-opioid receptor (MOR)
to inhibit neuronal activity and produces analgesia in part by activating OFF-cells and inhibiting ON-cells. Thus,
it follows that ON-cells express MOR. Numerous studies support the assertion that ON-cell circuitry is implicated
in chronic pain and opioid-induced hyperalgesia. However, until recently we lacked the genetic tools necessary
to dissect the circuitry of MOR-expressing neurons, including ON-cells, in the RVM. With the recent development
of the Oprm1-Cre knock-in mouse, we now have the genetic tool necessary to study these circuits in better detail.
The goal of this proposal is to therefore test the hypothesis that MOR+ RVM neurons facilitate pain by inhibiting
interneurons in the superficial dorsal horn. I will test this hypothesis using a combination of genetic, molecular,
electrophysiological, and behavioral approaches. Aim 1 will investigate which cell types in the RVM express
MOR through viral tracing, fluorescent in situ hybridization (FISH), and immunohistochemistry (IHC). Aim 2A will
identify the MOR+ RVM inputs received by interneurons in the dorsal horn through optogenetics and slice
electrophysiology. Aim 2B will explore the electrophysiological, neurochemical, and morphological phenotype of
dorsal horn interneurons receiving input from MOR+ RVM neurons using a combined electrophysiology and
anatomical approach. Aim 3 will test the hypothesis that MOR+ RVM neurons facilitate mechanical, chemical,
and thermal pain through the use of chemogenetics and behavioral assays of acute and chronic neuropathic
pain. The work detailed in this proposal is critically important because an enhanced understanding of the circuitry
underlying the RVM can pave the way for the development of novel pain therapeutics and will advance the field
of neuroscience.
Furthermore, this proposal is heavily inspired by my clinical interest in anesthesiology, where I plan to work as a
pain specialist and investigate pain signaling mechanisms to minimize patient suffering and improve quality of
life. The professional, technical, and intellectual skills which will be developed over the course of this fellowship
will position me for success as a physician-scientist in academic anesthesiology.

Public health relevance
Project Narrative Chronic pain is a debilitating condition which severely impacts quality of life for millions of people worldwide. Ascending pain signals undergo descending modulation by mu-opioid receptor (MOR)-positive neurons in the rostral ventromedial medulla (RVM) through circuits which are not completely understood. In this proposal, I will elucidate the specific circuitry through which MOR+ RVM spinal projection neurons facilitate pain using a combination of genetic, electrophysiological, and behavioral approaches.